Requirement of astrocyte-derived immune signaling for the hippocampal-cortical circuit for social novelty recognition

ABSTRACT
Although the neural mechanisms underlying social behaviors have been extensively studied, the role of glia,
such as astrocytes, has been less understood. Astrocytes play crucial roles in postnatal synaptic development
and function and contribute to information processing and cognition. Nevertheless, the role of astrocytes in the
synaptic refinement of neuronal projections into the medial prefrontal frontal cortex (mPFC), a key area in
social behaviors, has been less studied than in other brain regions, such as the thalamus. In the proposed
study, we will address the role of astrocytes in social novelty recognition, with a focus on the requirement of
astrocyte-enriched cytokine, interleukin-33 (IL-33) for a hippocampal-cortical circuit. IL-33 is a nuclear cytokine
abundantly expressed in astrocytes and oligodendrocytes and signals through its receptor, IL1RL1, on
microglia and some neurons in the developing and adult brain. We previously reported that mice lacking IL-33
(Il33-/- mice) exhibited social novelty recognition impairment without sociability deficits in the three-chamber
social interaction test. Our preliminary data have revealed that IL-33 deletion in astrocytes impairs social
novelty recognition and reduces neuronal c-Fos expression in the mPFC, indicating that the neuronal
projection from the ventral hippocampus (vHPC) to the mPFC may be attenuated. In addition, microglial
alterations are detected in Il33-/- mice during the early postnatal period. Thus, in the proposed study, we will
test our hypothesis that astrocyte-microglia IL-33 signaling is required for the postnatal synaptic
formation of the vHPC-mPFC projection, contributing to social novelty recognition. In Aim 1, we will
evaluate the structural and functional changes of the vHPC-mPFC projection and address its causal role in
social novelty recognition deficits in astrocyte-specific IL-33 deficient mice. In Aim 2, we will determine the
effects of microglial IL-33 receptor deletion and inducible astrocyte IL-33 deletion on the vHPC-mPFC
projection and social novelty recognition to assess the developmental requirement of astrocyte-microglia IL-33
signaling. Together, this exploratory study will assess the role of the vHPC-mPFC projection changes in social
novelty recognition deficits in the absence of astrocytic IL-33 and determine the developmental requirement of
astrocyte-microglia IL-33 signaling for the maturation of this key neural projection.

Public health relevance
Narrative Astrocytes and microglia play critical roles in synaptic development and function. This proposal outlines experiments designed to determine their requirement for the maturation of specific neuronal connections between the hippocampus and the cortex and social behaviors. The findings will create scientific foundations for a better understanding of the mechanisms underlying altered social behaviors and a potential future therapeutic intervention into psychiatric disorders.